Preventing Melanoma Metastasis by Targeting Lipid Vulnerabilities in Lymph

ABSTRACT
Although most melanoma deaths are caused by distant metastasis, the mechanisms that regulate metastasis
are poorly understood. During metastasis, cancer cells encounter oxidative stress in the blood, and successful
metastasis requires that cancer cells adapt to this hostile environment by undergoing metabolic changes. One
of the ways in which oxidative stress can kill cells is through ferroptosis, marked by the accumulation of lipid
reactive oxygen species. Recent work from Dr. Ubellacker’s studies discovered that melanoma cells in lymph
are protected against ferroptosis. These studies revealed that lymph protects from ferroptosis is by having high
levels of the monounsaturated fatty acid (MUFA) oleic acid, which shields cells from lipid oxidation by reducing
the abundance of polyunsaturated fatty acids (PUFAs) that undergo lipid oxidation in membranes. These
observations suggest that it may be possible to target lipid metabolism in cancer cells to prevent cancer spread
from lymph nodes. However, we do not know to what extent the lymph node microenvironment protects
melanoma cells from lipid oxidation. Nor do we know what lipidomic adaptations melanoma cells undergo in the
lymph node microenvironment enable them to metastasize more efficiently. The objective in this project is to
identify and exploit lipidomic vulnerabilities in melanoma cells in the lymphatic microenvironment to prevent early-
stage melanoma metastasis. To accomplish this objective, this project will use a clinically relevant model of
melanoma metastasis of patient-derived xenografts, as well as a murine melanoma model in immunocompetent
mice and human clinical samples The central hypothesis is that melanoma cells in the lymph node
microenvironment undergo specific lipid adaptations to withstand oxidative stress and that targeting these
adaptations will prevent melanoma metastasis from lymph nodes. The central hypothesis will be tested in three
specific aims: 1.) To investigate the extent to which melanoma cells depend on N-acylglycine synthesis for
survival in the lymph nodes, and whether this synthesis pathway can be targeted to decrease melanoma cell
survival; 2.) To assess the contribution of dietary and intracellular fatty acids to increasing lipid oxidation and
increasing death of melanoma cell metastases in lymph nodes; 3.) To determine the extent to which ferroptosis
resistance can be targeted to reduce survival of melanoma cells in lymph nodes. By identifying the influence of
the lymph node microenvironment on lipidomic changes in melanoma cells, we expect to determine lipids in
melanoma cells that serve as prognostic biomarkers and to identify feasible lipidomic targets and dietary
interventions to prevent the spread of early-stage melanoma and improve disease outcome in patients.

Public health relevance
PROJECT NARRATIVE Our work has the potential to dramatically impact public health because by determining the influence of the lymph node microenvironment on lipidomic changes in melanoma, we will be able to 1.) identify feasible lipidomic targets to prevent death from cancer spread from lymph nodes and 2.) determine lipids in melanoma cells that serve as prognostic biomarkers for metastasis and thus identify patients who could be spared the side effects of undergoing surgical resection of lymph nodes. Furthermore, we will elucidate how lipids modulate the lymphatic microenvironment to influence melanoma metastasis, which will offer important evidence linking lipid usage to risk of melanoma progression. Our work will provide the groundwork for future research efforts to develop novel therapeutic strategies to prevent progression of early-stage melanoma, with applicability to other cancer types as well (e.g., prostate, lung, breast cancer) by modulating the lymphatic microenvironment.